Admin-Core-001

The Administrative Core will coordinate the overall interactions among the two projects and scientific core
facility of the proposal. The Core Principal Investigator, Dr. Chris Larsen, will provide oversight and
leadership to the program project, administer the projects and scientific core, and promote collaboration
within the group and across the Steering Committee through the following specific aims: 1) To provide the
general administrative infrastructure in budgeting, purchasing, administration and fiscal reporting necessary
to run a complex program project grant; 2) To provide specialized expertise in animal use regulatory issues
and scientific reporting, to allow the project investigators to pursue their programs within the scope of
current regulations and technology; 3) To promote collaboration within the program project through the
coordination of meetings to present ongoing research and maintenance of cloud-based data sharing
infrastructure; 4) To coordinate participation in Steering Committee meetings, other NHPCSG activities,
and presentation of project data at national conferences; and 5) To provide statistical support for the
analysis of data generated by the projects.